Biology and Biophysics of the Cortical Response to Transcranial Magnetic Stimulation

The use of transcranial magnetic stimulation (TMS) as a therapeutic intervention is FDA-cleared for treating
depression, obsessive-compulsive disorder, and migraine, and shows promise for a host of other brain disorders.
The appeal of TMS is its safety, non-invasiveness, and well-established capacity for modulating the activity of
brain regions. In human subjects, that modulation is assessed only at the gross scale of behavioral, cognitive,
or aggregate physiological effects (e.g. EMG, EEG, fMRI). The fine-scale responses and mechanisms of TMS,
at the level of biophysical and biological effects on neurons and circuits, remain poorly understood. This
knowledge gap hinders rational design of TMS protocols and leaves researchers and clinicians dependent on
trial-and-error approaches and inferences from macroscopic data to improve the methodology. The lack of
reductionistic insight is particularly detrimental when targeting non-motor areas such as prefrontal cortex where
a readout of the immediate neural response is unavailable, for example due to the stimulus artifact in EEG. Our
overall goal is to fill in this knowledge gap by studying the neural circuit mechanisms of TMS in the non-human
primate brain. The approach integrates neurophysiological experiments featuring direct single-unit and local field
potential recordings and multiscale computational simulations of neural circuits in both primary motor cortex and
prefrontal cortex. Aim 1 is to establish the circuit mechanisms of acute responses to single and paired TMS
pulses. Determining the pulse response of single neural elements and recurrent cortical circuits permits a
detailed examination of the biophysics and biology of neural recruitment at a short time scale. A main goal of
TMS therapy is to achieve controlled, lasting neuromodulation, however, so in Aim 2 we will extend the same
neurophysiological and modeling approaches to the study of responses to repetitive TMS (rTMS). Here the goal
of the neurophysiology will be to quantify the effects of rTMS pulse trains on long-lasting changes in neural
activity and, accordingly, the neural simulations will incorporate synaptic plasticity. Critically, in both Aims we will
conduct the experiments and modeling both in primary motor cortex, where spinal potential recordings and
electromyography can supplement direct readout of neural effects in cortex, and prefrontal cortex, where only
cortical-level recordings are suited to characterize neuromodulatory effects. The overall product will be an
experiment- and model-driven mechanistic understanding of the effect of TMS on cortical circuits, enabling a
transformational advance in the interpretation of the effects of TMS. Taken together, the results will promote a
more biologically-grounded, rational approach to designing TMS protocols for neuromodulation.

Public health relevance
A major approach for treating brain disorders non-invasively is application of a transient magnetic field to the head, a procedure called transcranial magnetic stimulation (TMS). The effects of TMS are relatively weak, however, and help only a minority of patients, likely due to unoptimized protocols for applying the stimulation. This project will use recordings of nerve cells in the brain, paired with models of brain activity, to reveal the fine- scale mechanisms of TMS and promote biologically-founded improvements to its use.